Clinical Therapeutics

PROJECT SUMMARY/ABSTRACT
This NIH T32 postdoctoral training program in Clinical Therapeutics at the University of Chicago (UC)
represents a diverse, nurturing, and scientifically stimulating environment whose educational purpose is the
advanced research training of clinicians and translational scientists in clinical pharmacology,
pharmacogenomics and therapeutics, with a goal of sustaining and expanding the future workforce within
these important fields. Accredited by the American Board of Clinical Pharmacology, our training program
operates within the rigorous educational and research climate of the UC Committee on Clinical
Pharmacology and Pharmacogenomics (CCPP), a formal interdepartmental academic unit responsible for
the administration of the training program and housing its research and training faculty. Peter H. O’Donnell,
MD, CCPP Chair, directs the program along with Mark J. Ratain, MD. The multi-PD/PIs are assisted in
program leadership by an Executive Committee, a Fellowship Recruitment and Selection Committee, an
Education Committee, and an External Advisory Committee. Within UC, the program fulfills an exclusive
niche, providing focused training to individuals having a clinical background (MDs, MD/PhDs, PharmDs,
PharmD/PhDs, or select PhDs with a clinical focus). Many trainees enter the program while also pursuing
subspecialty clinical fellowship training. This opportunity for dual fellowship training within a chosen
subspecialty clinical area combined with clinical pharmacology creates a foundational research expertise
that promotes the development of impactful scientific contributions within the realm of clinical therapeutics.
Our fellowship program provides primary protected research time for advanced training in a chosen
research area, structured as a mentored, hypothesis-driven two-year arc designed by the trainee and their
mentor(s) and approved by the Executive Committee. This is supplemented by formal programmatic
didactic coursework, experiential learning rotations, teaching opportunities, and clinical exposure in
personalized therapeutics through a required rotation in the UC Personalized Therapeutics Clinic. Although
the primary mission is to prepare clinicians for an academic research career, the program also has
successfully trained scientists for prominent careers in government and industry. Upon completion of the
program, graduates are accomplished in basic research methodology, experimental design, and data
interpretation and presentation, and are uniquely prepared for a competitive research career in clinical
therapeutics, as well as certification in Clinical Pharmacology.

Public health relevance
PROJECT NARRATIVE This postdoctoral training program in Clinical Therapeutics is the core function of the Committee on Clinical Pharmacology and Pharmacogenomics at the University of Chicago and has the goal of providing advanced research training for clinicians and translational scientists in the areas of clinical pharmacology, pharmacogenomics, and therapeutics. Upon completion of the program, graduates are accomplished in state- of-the-art research methodology, experimental design, and data interpretation and presentation, and are uniquely prepared for a competitive research career in clinical therapeutics, as well as certification in Clinical Pharmacology.